Role of epigenetic changes in intracellular survival and replication of Legionell pneumophila

1 Legionella pneumophila is an opportunist pathogen that infects an immune-compromised host and causes
2 inflammatory pneumonia in the lungs termed as legionnaire’s disease. L. pneumophila infects alveolar
3 macrophages within the lungs and using a type IV secretion system, discharges an array of more than 300
4 proteins called effectors that interfere with the cell’s biochemical pathways to prepare a cozy niche for the
5 bacterial replication. Several recent studies also indicate that L. pneumophila infections in primary mouse
6 macrophages and protozoan cells manipulate host transcriptome and result in differential gene expression in the
7 infected host cell to facilitate their survival and evasion of the immune mechanisms. However, the mechanisms
8 involved in gene expression alterations are not clear and undefined. A comprehensive localization analysis of
9 Legionella effectors using GFP-tag revealed that a few of these Legionella effectors translocate into the nucleus
10 of the cell. An effector protein with an objective localization into the nucleus to modulate gene expression of the
11 host is called nucleomodulin. Recent studies indicate that several bacterial pathogens produce nucleomodulins
12 that aid in survival and pathogenesis through transient or long-term epigenetic modifications. In our prior work,
13 we identified five Legionella nucleomodulins with unknown function and the purpose of this study is to elucidate
14 the role of the Legionella nucleomodulins in understanding the pathogenesis of L. pneumophilia.
15 To better understand the effect of Legionella nucleomodulins on the host cells and determine their function
16 during the growth of Legionella pneumophila, we examined the differential gene expression pattern by
17 performing RNA sequence analysis on RNA extracted from mammalian cells expressing Legionella
18 nucleomodulin. The pathways and genes identified through functional analysis of RNA-seq data support
19 epigenetic modifications of host cells through methylation and histone modifications. The first objective of this
20 study is to examine the DNA methylation pattern on macrophages infected with L. pneumophila using Bisulfite
21 sequencing and methylation assays in comparison to uninfected macrophages. The second objective examines
22 interaction of Legionella nucleomodulin with histone and non-histone proteins by using chromatin
23 immunoprecipitation sequencing and co-immunoprecipitation assays.
24 The proposed research aims to detect transcriptional responses of a cell to its environmental influence such
25 as infections and understand how bacterial nucleomodulins mediate regulatory control through epigenetic
26 changes during an infection by intracellular pathogens to trigger altered gene expression patterns in the host cell
27 and manipulate cellular processes. As these mechanisms are ambiguous, this study will contribute to better
28 understanding of bacterial nucleomodulins and their role in bacterial pathogenesis which can help in designing
29 new therapeutic approaches. Additionally, this project will expand research and education experience for
30 undergraduate students at Western Kentucky University.

Public health relevance
Project Narrative Emerging pathogens are continuously evolving their infective mechanisms to alter host cellular responses to establish a niche and successful infection. In the wake of increase in Legionnaires outbreaks, the ability of Legionella pneumophila, to modulate diverse number of eukaryotic cell processes to survive and multiply in macrophages, is of public health concern. Thus, in-depth understanding of infection strategies from Legionella studies can help to design effective therapeutic strategies and preventive measures against intracellular bacterial pathogens.